Investigating the molecular mechanisms of Ca2+ selectivity and Ca2+ potentiation of the mitochondrial calcium uniporter

Project Summary/ Abstract
The mitochondrial calcium uniporter mediates Ca2+ uptake into mitochondria and thereby regulates metabolism,
cell death, and cytoplasmic Ca2+ signaling. How the Uniporter catalyzes ion permeation and achieves ion
selectivity are not well understood. The Uniporter is a supercomplex of protein subunits, containing at least:
MCU, EMRE, MICUs 1-3, MCUR1, and MCUb. The mechanism of Ca2+ selectivity and how the subunits control
gating of the channel have not been fully resolved, in part, because of the difficulties associated with studying
the function of the Uniporter in a purified context. The goal of this proposal is to understand the mechanisms of
Ca2+ selectivity and MCUR1 regulation of the Uniporter. I will take a reductionist approach to investigate these
processes using purified components. Through a blend of structural (cryo-EM) and functional
(electrophysiological) approaches, I will determine critical residues for selectivity of Ca2+ ions in the pore and I
will determine if the pore operates in a multi-ion fashion (Aim 1). Additionally, I will determine interactions of
MCU-EMRE-MCUR1 (MER) holocomplex that are involved in gating (Aim 2). I hypothesize that high Ca2+
selectivity through the pore is mediated by a multi-ion pore mechanism (Aim 1) and that MCUR1 promotes Ca2+
uptake through inhibition of Ca2+ dependent inactivation (Aim 2). The complementary use of single-particle cryo-
EM and planar lipid bilayer electrophysiology will define principles that underline ion selectivity and gating.

Public health relevance
Project Narrative The mitochondrial calcium channel known as the Uniporter regulates a wide array of cellular functions, which include ATP synthesis and programmed cell death. This proposal seeks to gain a molecular understanding for aspects of how the Uniporter functions. By studying this complex machinery, I hope to not only understand fundamental properties of the Uniporter, including its mechanisms for channel gating and ion selectivity, but also to provide fundamental knowledge for future researchers to utilize in treating diseases associated with mitochondrial disfunction.